Development and implementation of pediatric mobile phone reflectance pulse oximeters and a hypoxemia surveillance system in South Africa

PROJECT SUMMARY:
This is a submission for a National Institutes of Health R21/R33 award aiming to develop and validate a
context-appropriate, inexpensive mobile phone-based pediatric reflectance pulse oximeter compatible with an
interoperable hypoxemia surveillance system (R21 period), and then to evaluate the field implementation of a
mobile phone reflectance pulse oximeter and hypoxemia eHealth system using a cluster, randomized
controlled trial (R33 period). Lower respiratory infections (LRIs) are the leading infectious cause of death
globally among children below five years of age in low-income and middle-income countries (LMICs).
Hypoxemia, a low oxyhemoglobin saturation, is a key indicator of elevated LRI mortality risk. Pulse oximeters
are devices that non-invasively measure the peripheral oxyhemoglobin saturation (SpO2) to identify
hypoxemia, but are not widely available in LMICs for children, especially at primary healthcare clinics where
children first access care. Although oxygen is potentially a life-saving treatment for hypoxemic LRIs, health
systems in LMICs do not have well established oxygen systems to appropriately match supply with demand to
optimally benefit children.
We aim to develop, validate, and rigorously evaluate the implementation of an innovative, inexpensive
mobile phone-based reflectance pulse oximeter, embedded within an electronic health DHIS2 platform for real-
time hypoxemia diagnosis and surveillance of children in LMICs. We hypothesize that the pulse oximeter's
performance will be valid and that its implementation within a DHIS2 electronic health platform will address key
implementation endpoints in a conceptual framework and theory of change construct for improving pediatric
LRI mortality in LMICs. To accomplish our overall project goal we will build upon our prior successful pediatric
pulse oximeter development work in sub-Saharan Africa and South Asia using an innovative, multidisciplinary
product development process called human centered design. During the two-year R21 period we will apply the
human centered design approach to develop a mobile phone-based reflectance pulse oximeter and eHealth
system (Aim 1). The device will be validated in a breath-down laboratory and field tested in various clinical
settings with a range of practitioners in Cape Town, South Africa. We will then implement the pulse oximeter
and DHIS2 system within a large township in Cape Town, South Africa and conduct a cluster, randomized
controlled trial to evaluate implementation fidelity as the primary outcome (Aim 2), as well as secondary
outcomes of implementation acceptability and feasibility.
Successful completion of the research described in this application could lead to broader scale-up of an
affordable, sustainable interoperable hypoxemia eHealth system with advanced but accessible mobile phone
technology contextually appropriate for LMICs, where most pediatric deaths from hypoxemic LRIs occur.

Public health relevance
PROJECT NARRATIVE: Lower respiratory infections are the leading infectious cause of death for children younger than five years of age in low-income and middle-income countries (LMICs) like South Africa. Innovations in the identification of severe pediatric respiratory diseases complicated by low oxyhemoglobin saturation levels (hypoxemia) that are suitable for use in rural communities of LMICs are urgently needed to reduce mortality. An affordable mobile phone-based reflectance pulse oximeter with electronic health diagnostic and surveillance capabilities that is also contextually appropriate for LMICs offers an exciting potential for improving outcomes for severe pediatric lower respiratory infections.